Novel diagnostic biomarker reference standards for newborn screening of Mucopolysaccharidoses type I and II.

Project Summary
The goal of this project is to design and prepare diagnostic biomarker reference standards for the
endogenous glycosaminoglycan (GAG) Mucopolysaccharidosis type I (MPS-I) and type II (MPS-
II) biomarkers. MPS-I and MPS-II are lysosomal storage disorders (LSDs) which are listed on the
Recommended Uniform Screening Panel (RUSP) in the United States and are included in global
Newborn Screening (NBS) programs and Pilot studies currently ongoing. One issue with the first-
tier enzyme activity screening is the high prevalence of false positives, which may be eliminated
by second-tier biomarker screening. The endogenous GAG biomarker method has been shown
in recent studies to provide accurate discrimination of diagnosed newborns from the reference
range of healthy newborns and newborns with pseudodeficiencies (for MPS-II). Additionally, by
this method unique biomarkers have been identified for each disease, which will aid diagnostic
labs in clinical evaluation. Currently, no chemically identical, quantified reference standards
(which meets recommendations from FDA guidance on bioanalytical method validation) are
available on the market. The GAG disaccharide internal standards prepared within the scope of
this project will meet the reference standard recommendations indicated by the FDA, which are
not currently met by any other product on the market. As a result, GelbChem will be the first
supplier of all materials needed to complete bioanalytical validation of the endogenous GAG
biomarker method for MPS-I and MPS-II.

Public health relevance
Project Narrative: Newborn screening for treatable lysosomal storage diseases is warranted since initiation of treatment soon after birth leads to a better treatment outcome. Our research team has developed technology for newborn screening of a series of lysosomal storage diseases which is commercialized by our business branch (GelbChem, LLC). This proposal aims to develop and provide certified standards for a new biomarker assay for second-tier screening and clinical diagnosis of the genetic diseases MPS-I and MPS-II.